PARTIAL SLEEP DEPRIVATION MEASURED BY EEG, HMPAO-SPECT &RATING SCALES

Perform detailed analyses of nocturnal polysomnography before and after a night of partial sleep deprivation in depressed patients compared to normal controls. Analyze SPECT cerebral blood blow data in subjects for correlations with EEG changes.